National Eye Health Education Program (NEHEP)

The goal of NEHEP is to ensure that vision is a health priority by translating eye and vision research into public and professional education programs. NEHEP supports collaboration among eye health professionals, healthcare providers, patients, and the public.